Advancement to Clinical Candidate of Novel, Potent and Selective Chikungunya virus inhibitor series

? DESCRIPTION (provided by applicant): Novel therapies for the treatment of Chikungunya virus (CHIKV) infections are urgently needed to address the alarming spread of this pathogen across the Americas. We have identified a series of potent, selective, and orally bioavailable inhibitors of CHIKV replication. In this Direct to Phase project, we will optimize this series of CHIKV inhibitors to Pre-Development stage and advance a first ever CHIKV antiviral candidate to IND-enabling studies. To accomplish this task, we will execute an integrated medicinal chemistry optimization/biological profiling campaign to optimize the potency, drug-like properties and oral exposure of the series. One or more Pre-Development Candidates will be identified and advanced through candidate selection studies into non-GLP repeat-dose tox in both rats and dogs.

Public health relevance
PUBLIC HEALTH RELEVANCE: A Chikungunya virus (CHIKV) epidemic has exploded across the Caribbean as well as South and Central America and now threatens the continental U.S. The long term sequelae associated with CHIKV infection includes severe, debilitating polyarthralgia and musculoskeletal pain that can persist for several months to years in a significant fraction of individuals. There are no antiviral agents or vaccines approved for the treatment or prevention of CHIKV infection. Here, we propose to optimize a novel lead series of CHIKV inhibitors to Pre-Development stage and position a Development Candidate for IND-enabling studies.